METHODS FOR ANALYZING PRENATAL CARE--COHORT VERSUS CONDITIONAL ANALYSIS

This project involves the analysis of Missouri vital statistics data to determine if using a cohort method of analysis is biased in understanding the effect of prenatal care on pregnancy outcome. Cohort methods appear to underestimate the effect of prenatal care and suggest that late entry into prenatal care is more beneficial than early entry.